ARTEMIS: Advancing Addiction Research and Treatment through Engagement with Rural Marylanders Impacted by PolySubstance Use

ABSTRACT. Despite the significant increase in overdose-related deaths in the past decade, there continues to
be a substantial gap in getting services to the individuals who need it most, particularly for individuals with
polysubstance use in rural areas. To bridge this gap, clinical research and services must incorporate
perspectives of individuals with polysubstance use in rural areas—voices that are often neglected from the
research process and care delivery decisions. This proposal builds upon our team’s expertise in developing
patient research advisory boards to advance addiction treatment by developing a novel patient engagement
resource center (ARTEMIS: Advancing Addiction Research and Treatment through Engagement with Rural
Marylanders Impacted by PolySubstance Use). This proposal is directly responsive to patient feedback to create
a novel patient engagement resource center focused on improving services for individuals with polysubstance
use in rural areas. Our team has conducted preliminary work, including to: (1) establish an urban Research
Advisory Committee of individuals with lived experience of substance use to inform and accelerate addiction
research; and (2) capture patient-defined barriers to treatment and successful treatment outcomes. Our
interdisciplinary team at UMD has a strong history of collaboration with communities and patients, including
five rural county health departments, and has established an innovative network of clinical services throughout
rural Maryland, including a unique mobile telemedicine unit offering telemedicine buprenorphine prescribing and
peer recovery services. We have created a framework for peer-focused clinical research at these sites, led by MPIs
Kattakuzhy and Magidson (R01DA057443), offering an opportunity to build upon this infrastructure for ARTEMIS.
The overall aim is to establish a sustainable patient engagement resource center to advance patient-centered,
integrated care models for polysubstance use in rural areas. Specific aims are to: 1) Form a patient advisory
committee and consultation model focused on individuals with polysubstance use in rural areas, guided by the
Framework for Continuous Patient and Stakeholder Engagement in Patient Centered Outcomes Research
(PCOR); 2) Evaluate patient experiences with polysubstance use care delivery in rural areas to document
perceived barriers, preferences and strategies for improving service delivery; 3) Conduct pilot projects designed
in partnership with the PAC, with a proposed focus on: a) Understanding patient experiences of polysubstance
use, including intentions for and patterns of use; and b) Identifying strategies for addressing social determinants
of health and improving functional outcomes. These pilot studies were guided by our team’s preliminary research
and patient input, and the study designs will ultimately be based on feedback from Aims 1 and 2. ARTEMIS will
leverage the team’s unique strengths to engage in meaningful dialogue with patients with polysubstance use to
create a national model for urban-rural academic-community partnerships, and re-center the patient experience
of polysubstance use in clinical research and treatment.

Public health relevance
Project Narrative The ARTEMIS project will establish an advisory panel to engage individuals who have lived experience with polysubstance drug use and reside in rural communities, a markedly under resourced and high-risk focal population. The team will utilize and leverage patient insights to help identify and address barriers to treatment as well as gaps in systems of service delivery to improve access and engagement. This panel will serve as a resource to support providers and researchers in integrating patient perspectives with the treatment and study of substance use disorders.